Advancing Image Data Interoperability and Standards within an NIH Ecosystem (AIDISNE): A CHOP, FlyWheel, and Seven Bridges Integration Demonstration Project

PROJECT SUMMARY
Our research plan includes three components that address an end-to-end use-case-driven framework that:
(1) will demonstrate the ingestion, publishing, and requisition of imaging data by integrating the FlyWheel
Platform within the INCLUDE Ecosystem; (2) will provide for platform and workspace interoperability features
between CAVATICA and the FlyWheel Platform, and (3) leverage and support the further extension DRS
and FHIR to support imaging data in parity and alongside clinical and genomics data within the INCLUDE
Data Hub, a FHIR-first portal. The research plan aims to address Imaging Gaps by completing demonstration
projects that further define and delineate the extensible requirements for integrating imaging data with
existing NIH-funded ecosystems, define minimal interoperability requirements across platforms and
workspaces by developing functional implementations, and translating these requirements into best practice
through standard development within the NIH Cloud Platform Interoperability (NCPI) effort.

Public health relevance
PROJECT NARRATIVE To date, to our knowledge, imaging data has not achieved operational, end-to-end physicality that is either equivalent to or interoperable with genomics or other clinical data. To our knowledge, while imaging data repositories exist across NIH, such data is not cloud enabled in ways that support 1) a framework of controlled/open access management, 2) reproducible workflows and provenance as deployed within collaborative, interoperable resources 3) interconnected resources that would enable multimodal, large-scale analyses across genomic, clinical, imaging data features as part of an AI ready resource. A combination of developing resources in which the INCLUDE team has participated are poised to enable addressing the above and additional gaps by innovating on a combination of both platform- and workspace-interoperability and the implementation and further coordinated development of emerging standards within the NIH cloud-based ecosystem of Fast Healthcare Interoperability Resources (FHIR) and Data Repository Service (DRS) standards